Time2Connect: An Adapted Loneliness Intervention for Older Adults with MCI or Mild ADRD in Primary Care

PROJECT
SUMMARY
Loneliness
and
is a significant health issue for older adults and is a major risk factor for morbidity
mortality, including for older adults with Alzheimer's disease and related dementias
(ADRD). Loneliness interventions are a promising strategy to improve health outcomes in older
adults with ADRD. As
care
t he frontline entry to health care for most older adults in the US, primary
is an ideal setting to intervene on loneliness.Unfortunately, there is a lack of loneliness
interventions tailored to older adults with cognitive impairment in the primary care setting. This
proposal aims to address this gap by adapting an evidence-based creative storytelling
intervention for older adults with cognitive impairment, called TimeSlips, for the primary care
setting.
aims
older
0),
(NIH
Time2Connect,
support
has
coursework,
human-centered
Mullen
experience
and
funded
Guided by the NIH Stage Model for Behavioral Intervention Development, the study
are: 1) Assess potential psychosocial mechanisms of loneliness in community-dwelling
adults with a high prevalence of mild cognitive impairment (MCI) or mild ADRD (NIH Stage
2) Adapt the TimeSlips intervention for older adults with MCI or mild ADRD in primary care
Stage 1A), and 3) Conduct a pilot randomized trial of the adapted i ntervention, called
for older adults with MCI or mild ADRD (NIH Stage 1B). This proposal will
the research and career development of the candidate, Dr. Rebecca Mullen . Dr. Mullen
developed a detailed career development plan consisting of mentorship, didactic
and hands-on experience t o expand her knowledge in mixed methods research,
design for intervention adaptation and development, and clinical trials. Dr.
has assembled multidisciplinary team of mentors with extensive clinica l research
and content expertise to ensure her success in achieving the stated research aims
career goals. This K23 proposal wil l allow Dr. Mullen to transition to an independently
primary care physician-scientist
a
with expertise in loneliness intervention to improve the
health outcomes for older adults.

Public health relevance
PROJECT NARRATIVE Loneliness with loneliness and older dementia interventions are a promising strategy to improve health outcomes for older adults cognitive impairment. This study will assess the potential psychosocial mechanisms of in community-dwelling older adults with a high prevalence of cognitive impairment will use human-centered design to adapt and pilot an intervention to reduce loneliness in adults with mild cognitive impairment (MCI) or mild Alzheimer's disease and related (ADRD) in primary care.